LASER MICRODISSECTION OF CHROMOSOME Q34 REGION FOR SPECIFIC DNA LIBRARIES

We recently demonstrated that laser microdissection has the advantage of more accurate chromosome targeting and less contamination than needle microdissection. Using a laser to damage the surrounding chromosomes before collection of the target chromosome prevents the coincident picking of non-target chromosomal DNA nearby. The chr9q34 micro-library we generated by laser microdissection followed by PCR applification and cloning contains around 10,000 clones with an average insert size of about 450bp. Compared to our chr9q34 micro-library generated by needle dissection using the same cloning strategy, the laser microdissected library has larger than average insert size and greater coverage of the chromosomal region.